Contribution of locus coeruleus activity patterns on tau deposition in Alzheimer's disease

ABSTRACT
Alzheimer's disease (AD)'s neuropathologic hallmarks are the accumulation of amyloid-beta (Aβ) and tau
proteins. Thus far, therapeutic efforts have been mainly focused on Aβ and showed limited success, underscoring
the need for alternative approaches of intervention, particularly those that can target mechanisms related to the
initial propagation of pathology. The locus coeruleus (LC) has been identified as one of the earliest regions
affected by tau: by the age of 40, 80% of individuals exhibit tau aggregation in the LC, and by the age of 50, 50%
of individuals exhibit tau aggregation in the entorhinal cortex (EC), suggesting tau progression from the LC to
the medial temporal lobe (MTL). However, the mechanism of tau propagation is yet unknown. Accumulated
evidence from animal research suggests that pathologic tau propagates via axons and cell-to-cell transmission
and that synaptic and neuronal activity levels facilitate this process. Furthermore, a recent study using a rat
model of pretangle tau in LC neurons and optogenetic stimulation suggested that novelty-like phasic LC
activation protects against the deleterious changes linked to pretangle tau. In contrast, stress-associated tonic
LC activation worsens LC neuronal health and promotes depressive behaviors that have been associated with tau
accumulation in the EC. Our own preliminary data shows that lower novelty-related LC activation is related to
higher tau deposition in the EC and steeper memory decline in cognitively healthy older individuals. This
evidence forms the scientific premise for the hypothesis that phasic versus tonic resting-state LC activity may be
associated with mechanisms of tau propagation and ultimately predict cognitive decline. The goal of this proposal
is to examine the relationship between the balance between phasic versus tonic LC activity detected in resting-
state fMRI data and tau deposition in the EC and the MTL across all stages of the AD continuum and cognitive
decline. To achieve this, we will resolve two methodological barriers: (ii) accounting for the hemodynamic
blurring in resting-state fMRI using deconvolution in terms of an optimally defined region- and subject-specific
hemodynamic response function, and (ii) using novel event-detection techniques for the detection of periods of
phasic and tonic activity in the deconvoluted LC. Our methodology for quantifying the balance between phasic
versus tonic LC activity will be fine-tuned and validated using simultaneous LC BOLD-fMRI, fiber photometry
calcium imaging, and pupil dilation data collected from awake rodents during resting-experimental conditions.
Combining these state-of-the-art novel methods with tau-, Aβ-PET, and longitudinal cognitive data from the
Harvard Aging Brain Study and the Alzheimer Disease Neuroimaging Initiative, will allow us to examine the
following aims: Aim 1) To investigate the associations between cross-sectional patterns of LC activity with age,
sex, tau, and beta-amyloid pathology among individuals of varying biomarker levels, Aim 2) To relate LC
activation patterns to cognitive decline as a function of AD pathology. Together, these aims contribute to our
understanding of the mechanistic underpinnings of initial tau propagation and its relevance for cognition.

Public health relevance
NARRATIVE The locus coeruleus, a minuscule region in the dorsal pons, is important for cognition and one of the first regions to accumulate pathologic tau proteins. The proposed study aims to apply novel methods in two large-scale longitudinal cohorts to examine whether the patterns of locus coeruleus activity contribute to the propagation of tau from the brainstem to the entorhinal cortex, the first cortical region accumulating tau, and ultimately leading to cognitive decline. This project has important public health implications and is relevant to part of the NIH’s mission as it will provide insight into the mechanisms of propagation of tau pathology during the primitive stages of Alzheimer's disease and can provide new targets for treatment before irreversible damage has occurred.